Administrative Core

Project Summary/Abstract: Detroit has the highest preterm birth rate of the 100 US cities with the greatest number of births, and volatile organic chemicals are potential etiologic factors, likely due in part to their migration from Superfund sites to locations where human exposures can occur. The Center for Leadership in Environmental Awareness and Research (CLEAR) is dedicated to understanding and mitigating this serious environmental health problem, as well as working with our community, government agencies, and other stakeholders to increase awareness about this problem and cultivate a cohort of leaders to mitigate it. The CLEAR Administrative Core is the integrative hub that provides experienced leadership, business management, structures for communication and coordination among Center research projects and cores, processes for research translation to stakeholders, and mechanisms for evaluation and adjustment of Center activities to reduce the impacts of volatile organic compounds on both public and environmental health. In Aim 1, the Administrative Core, co-led by Melissa Runge-Morris, MD, and Carol Miller, PhD, PE, will coordinate essential centralized operational activities by providing strong leadership, managing Center business operations, communicating CLEAR operational activities to project and core leaders through monthly meetings of the Internal Advisory Committee, coordinating biannual meetings with the External Advisory Committee, communicating regularly with University leadership to ensure strong institutional support, and communicating regularly with SRP staff to report progress and ensure that CLEAR remains well-aligned with the SRP mission. In Aim 2, the Administrative Core will facilitate interdisciplinary interactions among CLEAR projects and cores through its monthly Internal Advisory Committee meetings, a weekly seminar series, quarterly half-day “progress-pulse” workshops, and an annual thematic symposium. In Aim 3, the Administrative Core will accomplish research translation via an accomplished team with a unique blend of expertise in environmental health communication, environmental and public health law, user-centered information design and communications, and economic impact analysis, who will disseminate information about CLEAR research advances and program events to internal and external stakeholders that include academics, SRP staff, policymakers and government actors, community partners, and technology development partners, using a targeted communication strategy that includes publication, media dissemination, digital platforms, policy papers, annual reports, briefing sessions, community art exhibits, and symposia. Aim 4 is devoted to Center self-evaluation and will include implementation of “Operational and Strategic Dashboards” to visualize metrics of performance against the Center’s goals, thereby providing an objective means to align strategy with tactics, ensure a goal-driven and performance-based data culture, and encourage interactivity and analysis throughout all components of the Center.

Public health relevance
Project Narrative The Center for Leadership in Environmental Awareness and Research (CLEAR) has built an integrated, transdisciplinary framework, rooted in advanced techniques in environmental engineering and biomedical research, to address human exposures to volatile organic compounds (VOCs) and health risks in urban areas. Research findings on (a) the relationship between VOC exposure and human health risks—for preterm birth and associated adverse health outcomes in particular—combined with (b) new methods and technologies to assess and reduce those health risks, and (c) a new understanding of related biological systems, will contribute to improved public health interventions. CLEAR research is expected to have a direct impact on affected communities, stakeholders, and the agencies responsible for Superfund site management and the reduction of environmental VOC exposure. The Administrative Core is the integrative hub for CLEAR that provides experienced leadership, business management, structures for communication and coordination among CLEAR projects and cores, processes for research translation to stakeholders, and mechanisms for evaluation and adjustment of Center activities.